Career E Core

The Career Enhancement Core (CEC) is essential for meeting the Center for Social Capital (SoCa) mission of
reducing cancer incidence in persistent poverty areas (PPAs). The SoCa CEC will implement a multipronged
approach to support early stage investigators entry, retention, and progression into conducting cancer health
disparities research among the most impoverished populations. To this end, we develop the SoCa Method which
we define as the development of a sustainable infrastructure for a social network where the established norms
of the network produce the expectation of entry, retention, and progression of investigators in cancer health
disparities, advancing the individual and the collective goals of the community. To this end, the CEC will leverage
existing programs and build needed programming, harmonizing collective efforts that activates and supports
sustained movement of early stage investigators across the biomedical enterprise with the expertise needed to
serve underserved communities. The CEC will support entry by developing web-based programmatic
infrastructure to identify and aid established investigators in securing diversity supplements (DSs) that will
support all eligible stages of early stage investigators (from as early as high school through junior faculty support)
who are dedicated to cancer health disparities in impoverished communities (Aim1). To retain early stage
investigators dedicated to serving underserved communities, we will implement a Clinical Research Coordinator
Training Program for undergraduates, post baccalaureates, and master’s students that will facilitate entry into
clinical coordinator positions within persistent poverty communities (Aim 2). To progress early stage
investigators, we will provide a personalized approach to team-based mentoring and training to bolster the
scholars’ ability to compete effectively for external research funding, to strengthen promotional packages, and
instill cancer research in PPAs within their portfolio (Aim 3).
The CEC objectives are leveraged by unparalleled resources including the outstanding training and
educational programs at Columbia University Irving Medical Center (CUIMC), Cornell University (CU), and
Downstate Health Sciences University (Downstate), as well as, available core resources including the Clinical
and Translational Science Awards (CTSA) and the affiliated Cancer Centers. The CEC will work collaboratively
with the SoCa Center Cores (Research and Methods, Development, and Administrative Core), Advisory Board,
and Projects to support the SoCa Center’s overall mission. The CEC will support the submission of ≥40 DSs,
clinical research coordinator training of 20 students, and personalized training of 12 SoCa Scholars across the
granting period. Supported by the Core Co-Directors (Drs. Yazmin Carrasco and Jasmine McDonald), SoCa
Center Faculty, and cross-institutional opportunities within and across CU, CUIMC, and Downstate - the CEC
will create sustainable and scalable infrastructures and programs that increase biomedical workforce diversity.